Interdisciplinary Regenerative Medicine Training Program(RMI)

DESCRIPTION (provided by applicant): The goal of this interdisciplinary training program is to train future leaders in Regenerative Medicine. The new discipline of Regenerative Medicine has arisen at the intersection of the frontiers of research in Developmental Biology, Bioengineering, and Clinical Medicine. This Program is truly interdisciplinary in nature and will expose trainees to Developmental Biology, Bioengineering, and the clinical consequences of tissue deficiencies/dysfunction in areas directly pertinent to each trainee's research. This interdisciplinary training program draws on the expertise of faculty from three schools at Stanford University: the School of Humanities and Sciences, the School of Engineering, and the School of Medicine. The Program will train students at two levels: predoctoral and postdoctoral. Each trainee will have a preceptor in whose laboratory he/she will spend the vast majority of their time, and a co-mentor representing a disparate scientific discipline. Predoctoral and Postdoctoral Committees will oversee the selection and monitoring of their respective trainees. Once in the program, the trainees will receive complementary training in the areas with which they have no previous experience. For example, a predoctoral candidate in Developmental Biology will take courses in Bioengineering. Unless trainees already have an MD degree, they will undertake a two-week clinical immersion rotation to expose them to the consequences of organ and tissue deficiencies/dysfunction in areas directly related to their research. In addition to their scientific training, trainees will acquire the leadership skills necessary to direct interdisciplinary research groups in the future. Finally, because our trainees will have an interdisciplinary education that includes Developmental Biology, Bioengineering, and Clinical Medicine, it is anticipated that they will contribute to the development of novel therapies to regenerate, repair, and replace deficient or dysfunctional tissue and organs.